Peptide Hormone Structure Function

DESCRIPTION (provided by applicant): The long term goals of this research are to develop a multi disciplinary research that provides a systematic, rational, three dimensional approach to the design and synthesis of potent receptor/acceptor selective peptide and peptide mimetic ligands for peptide hormones and neurotransmitter G-protein coupled receptors (GPCRs) with emphasis on the melanocortin receptors. This research requires a highly multidisciplinary approach including: computer assisted modeling;conformational analysis using 2D NMR spectroscopy and other biophysical methods;novel asymmetric synthetic methods;macrocyclicpeptide and peptidomimetic synthetic methods;the utilization of cloned GPCRs for binding and second messenger assays, and for examination of mechanisms of signal transduction;for evaluation of conformation-biological activity relationships that lead to receptor selective and potent peptides and peptidomimetics with specific agonist and antagonist biological activities;to develop a new biophysical method, Plasmon waveguide resonance (PWR) spectroscopy that allows for the first time direct observation of the structural changes that accompany ligand-GPCR interactions in membranes. Specifically, this grant will focus on ligands which are derived from propiomelanocortin peptides (e.g. alpha-MSH, gamma-MSH, etc.), and that interact with human melanocortin receptors MC1R, MC3R, MC4R and MC5R. Specific aims include: 1) development of novel asymmetric synthesis methods for novel amino acid and molecular templates which will be used in the design and synthesis of novel ligands which are potent and selective agonists or antagonists or inverse agonists for the hMC1R, hMC3R, hMC4R and hMC5R;2) their evaluation in binding affinity and second messenger assays, and examination by computational and biophysical methods of the conformational features that are critical for these potencies and receptor selectivities;and 3) use of a variety of biochemical, biophysical, and molecular pharmacology methods to examine the biological properties which lead to different signaling and/or which can explain the selectivity of these ligand and discover unique properties which can be used for further design of new ligands the enhanced properties in Specific Aim 1. PUBLIC HEALTH RELEVANCE: The melanotropin peptides are hormones and neurotransmitters that interact with their cognate receptors on the cell surface (melanocortin receptors) and affect many critical aspects of human health, disease and behavior. Important affects include feeding behavior, obesity, anorexia, pain, diabetes, pigmentary disorders, cancer, sexual response and motivation, immune response, and many others. We are developing highly selective agonists and antagonists for these systems and using these ligands to study the mechanisms of action that lead to these responses and to develop these ligands as potential drugs to treat diseases and behavior abnormalities.

Public health relevance
7. Project Narrative The melanotropin peptides are hormones and neurotransmitters that interact with their cognate receptors on the cell surface (melanocortin receptors) and affect many critical aspects of human health, disease and behavior. Importantaffectsincludefeedingbehavior,obesity,anorexia,pain,diabetes,pigmentarydisorders,cancer,sexual response and motivation, immune response, and many others. We are developing highly selective agonists and antagonists for these systems and using these ligands to study the mechanisms of action that lead to these responses and to develop these ligands as potential drugs to treat diseases and behavior abnormalities.